Improved Methods for In Vivo Hepatic Gene Therapy

DESCRIPTION (provided by applicant): Hepatic gene therapy could permanently correct tne clinical manitestations of a number of genetic deficiencies. Although retroviral vectors (RV) can transduce hepatocytes and result in long-term and therapeutic levels of expression in rodents, both the older Moloney murine leukemia virus (MLV) vectors as well as the newer lentiviral vectors only efficiently transduce dividing hepatocytes. We have demonstrated during the previous funding period that hepatocyte growth factor (HGF) can efficiently induce hepatocyte replication in rodents. Furthermore, it increased the percentage of hepatocytes that are transduced with an MLV-based RV by 20-fold over that observed in young adult animals that did not receive HGF. There were no obvious adverse effects of the HGF, and little or no effect upon replication or transduction in most other organs. Prior to using this approach in humans for gene therapy, it will be necessary to demonstrate efficacy and safety in a large animal model. The first aim of this project will be to determine if HGF can be effective and safe in neonatal or young dogs. Although the HGF has had no overt adverse effects to date, we remain concerned that the induction of replication may cause some loss of liver-specific functions, or may induce cancer. We will therefore use microarray technology in aim II to compare gene expression in HGF-treated with normal rats to determine if any critical liver-specific genes are downregulated. We will also analyze additional animals to determine if either HGF or RV integration result in cancer. The third and final aim will attempt to develop a safe method for amplifying transduced hepatocytes in vivo. All methods for stable gene transfer into the liver have been plagued by a transduction efficiency that is usually lower than 10 percent. Although this may be sufficient for the correction of some disorders, it may not be effective for others. Activation of Fas results in apoptosis in hepatocytes. Cells that express a downstream inhibitor of apoptosis, Bc12, do not undergo apoptosis, and can be selectively amplified in vivo. However, Bcl2 is a known oncogene that blocks apoptosis at a late step in response to a variety of stimuli, and would be inappropriate for use in gene therapy. We will test if we can block apoptosis at a more upstream step by using a dominant-negative Fas decoy receptor. Success in this project might lead to a safe, effective, and permanent therapy for genetic deficiencies that involve proteins synthesized by the liver.